Triglycerides, Diabetes and Cardiovascular Disease

The overall hypothesis of the Triglycerides, Diabetes and Cardiovascular Disease Program Project for the
next 5 years is that that abnormal assembly, secretion, composition and clearance of TRLs promotes
the accumulation of highly atherogenic RLPs in atherosclerotic lesions in individuals with T2D, and
that RLPs contribute to CVD risk by altering lesion cell populations and functions, thereby increasing
atherosclerotic lesion progression and hindering regression. We propose that the increased risk of
cardiovascular disease (CVD) associated with diabetes can be understood, prevented, and treated only by
increasing our knowledge of the factors that regulate triglyceride-rich lipoproteins (TRLs) and their remnant
lipoprotein particles (RLPs). TRLs and their remnants comprise a great variety of nascent and metabolically
derived particles differing in size, protein composition, and lipid content, which has made it difficult to identify
the mechanisms that promote atherosclerosis. We plan to continue to address this complexity by focusing on
specific pathways and proteins and by using unique analytical tools; building on the knowledge, methodology
and tools we have accumulated in the current funding period. We believe that our highly interactive and
interdisciplinary group of investigators with extensive expertise in this area is needed to answer the question of
how TRLs and RLPs promote CVD risk. The expertise of our team in different aspects pertaining to the overall
hypotheses of this Program Project will continue to ensure synergy and cross-fertilization between Projects,
which is likely to markedly advance research in this important and timely area. Importantly, the RLPs and
proteins that control them are amenable to therapeutic intervention. We therefore believe that our projects will
continue to provide new insights into the pathogenesis of CVD in diabetes and suggest new ways to target and
prevent the increased CVD risk in this large population. The Program Project Grant consists of three Projects
and three Core units:
• Project 1: Type 2 diabetes, APOC3 and cardiovascular disease – Karin E. Bornfeldt, PhD, Project
Leader
• Project 2: ANGPTL3-dependent mechanisms underlying adaptations in hepatic lipoprotein
production and clearance – Nathan Stitziel, MD, PhD, Project Leader
• Project 3: Triglycerides, lipolysis, and vascular inflammation – Ira J. Goldberg, MD, Project Leader
• Core A: Administrative Core – Karin E. Bornfeldt, PhD, Core Director
• Core B: Proteomics and lipoprotein characterization core – Tomas Vaisar, PhD, Core Director
• Core C: Atherosclerosis and bioinformatics core – Jenny E. Kanter, PhD, Core Director

Public health relevance
The proposed studies will have important implications for the management of patients with diabetes and prediabetes, in whom the risk of premature cardiovascular disease remains a serious threat. The investigations will provide important and interrelated insights into novel fundamental mechanisms of diabetic vascular disease, which in the long-term will set the stage for the development of new therapeutic agents and pharmacological strategies designed to prevent and interrupt the devastating complications of diabetes.